Centromere behaviors that promote proper chromosome segregation in meiosis and mitosis

Project Summary
In both mitosis and meiosis, success depends on accurately pulling partner chromosomes away from one
another on a spindle composed of microtubules. The microtubules attach to the chromosomes at their
kinetochores. When the partners errantly move to the same pole a chromosome imbalance is created,
producing cells with too many or too few chromosomes (aneuploidy). Meiotic errors produce aneuploid
gametes, the major cause of birth defects and infertility, while aneuploidy in somatic cells is associated with
tumor progression. The goal of this project is to elucidate mechanisms that allow chromosomes to correctly
attach to microtubules so they segregate appropriately in meiosis and mitosis. Three concurrent projects will
address this goal. Experiments in Project 1 will elucidate the mechanisms used to partition chromosomes in
meiosis I. When cells enter meiosis, homologous chromosomes are not connected to each other, but they
become linked by crossovers (chiasma). These linkages help homologous chromosomes to move away from
each other in meiosis I. The linkages transmit tension between the homologous centromeres when they
become attached correctly to microtubules from opposite sides of the spindle. Tension stabilizes these
attachments. A second kind of connection called centromere pairing allows the centromeres of model
chromosomes to become linked. Project 1 will explore the basis by which centromeres become connected by
centromere pairing and determine how often natural chromosomes rely on centromere pairing to ensure they
segregate correctly at meiosis I. Project 2 will define the biophysical properties of connections made by
centromere pairing and chiasmata in transmitting tension between centromeres. Project 2 will also investigate
whether chiasmata in different chromosomal positions have different biophysical properties that explain their
different abilities to ensure proper segregation. A final project focuses more on mitosis. Cells with abnormally
high chromosome numbers, for example many tumor cell lines and polyploid cells, rely on high level
expression of the cell cycle kinase Mps1 for their survival. The same is true for meiotic cells. Mps1 plays many
roles, but this Mps1-addiction of certain vulnerable cell types appears linked to a role for Mps1 in attaching
chromosomes correctly to microtubules in mitosis and meiosis. The experiments in Project 3 will test the
hypothesis that Mps1 mediates a form of chromosome movement called chromosome gliding that might help
chromosomes move to favorable positions on prometaphase spindles. Finally, genetic screens in Mps1-
addicted mammalian and yeast cells will be used to identify the vulnerable Mps1 pathways. These projects will
be collaborative and synergistic and reveal unique insights into centromere behavior in meiosis and
chromosome microtubule interactions in mitosis. They will include emerging technologies in budding yeast and
collaborative efforts that exploit other model systems to advance our knowledge of chromosome biology.

Public health relevance
Errors in the process of distributing chromosomes during cell division is the major cause of birth defects and contributes to tumor progression. The chromosomes are moved by microscopic cables. This project will explore how cells are able to attach chromosomes to these cables without errors, to assure that each daughter cell receives a correct chromosome set.